PROSPECTIVE COMPARISON OF HEPARIN PLUS UROKINASE VS HEPARIN ALONE

This study will compare the efficacy and safety of two therapeutic regimens (heparin vs. combined heparin and urokinase) for symptomatic thrombosis in newborn infants and children.